The role of anterior cingulate leptin signaling in modulating effortful reward seeking

PROJECT SUMMARY
Depression and metabolic syndrome are frequently comorbid and bidirectionally linked, yet our understanding
of how metabolic dysfunction impacts features of depression is limited. Anhedonia is a core symptom of
depression which encompasses deficits in reward processing including effort valuation, or the weighing of a
reward’s value against the effort necessary to obtain it. Due to the intrinsic relationship between effort and energy
expenditure, effort valuation represents a behavior that is both relevant to anhedonia and likely to be subject to
metabolic regulation. While studies exploring this possibility are lacking, several lines of evidence indicate that
the adipokine leptin, whose regulation is altered in metabolic syndrome, may serve as a metabolic input to neural
circuits supporting effortful valuation. For example, previous studies have demonstrated that leptin levels
correspond to adiposity and, on the basis of stored energy levels, regulate other processes tied to energy intake
and expenditure, such as appetite, fertility, and thermoregulation. Further, treatment of mice with chronic
corticosterone (CORT) induces effort valuation deficits while concomitantly increasing leptin levels and inducing
a leptin resistant phenotype that mirrors metabolic syndrome. Notably, CORT’s effects on effortful valuation are
associated with reduced activity in the anterior cingulate cortex (ACC), a brain region required for effort valuation
that contains a sparse population of excitatory neurons that express the leptin receptor (Lepr). Lastly, this putative
function of leptin is supported by our preliminary data which shows a CORT-induced downregulation of Lepr
expression in layer 2/3 excitatory neurons in the ACC, an effect that is reversed after treatment with ketamine, a
rapid-acting antidepressant. This result indicates a link between the CORT-induced hyperleptinemia and local
changes in ACC leptin signaling. Based on these data, we hypothesize that ACC leptin signaling, through
changing the activity of Lepr+ neurons, supports effortful reward seeking and mediates the effects of CORT-
induced metabolic dysfunction on effort valuation. In this proposal, we will first fully characterize the extent and
time course of CORT’s metabolic effects using metabolic chambers. This will then allow appropriately timed viral
manipulations of Lepr levels in the ACC neurons of transgenic mice, which will be used to determine whether
altered ACC leptin signaling is necessary and sufficient for the effects of CORT on effortful reward seeking
behavior. Next, we will use transgenic mice and viral expression of a fluorescent calcium indicator to determine
the effect of leptin signaling on the spontaneous activity of Lepr+ neurons in both control and CORT mice. Finally,
we will evaluate the role of Lepr+ neurons in supporting effortful reward seeking by recording and manipulating
their activity with fiber photometry and optogenetics, respectively, in behaving mice engaged in an effort valuation
task. Completion of the research proposed here will determine the role of ACC leptin signaling on effort valuation,
thereby improving our understanding of mechanisms mediating the relationship between metabolic dysfunction
and hedonic behavior.

Public health relevance
PROJECT NARRATIVE Effort valuation, or the weighing of an effort’s cost against the value of a reward, is disrupted in a variety of psychiatric disorders. The amount of energy available to perform effortful tasks is signaled in part by leptin, a fat- secreted hormone that is disrupted in metabolic syndrome. This study explores whether leptin plays a role in brain circuits that govern effort valuation, thereby improving our understanding of the relationship between metabolic and mental health.